Transcriptional Control of Skeletal Muscle Atrophy

Skeletal muscle atrophy results from insufficient nutrition, aging, certain medications, and a wide range of
medical illnesses including cancer, diabetes mellitus, heart or renal failure, and acute or chronic infections. It is
linked to increased disability, morbidity, as well as mortality, afflicts millions of Americans, and accounts for tens
of billions of dollars in annual healthcare costs. Moreover, veterans are projected to have an increased
prevalence of muscle atrophy compared to the general population because of military service-related injuries
and medical conditions as well as their older age. Yet, there are no currently approved medical therapies for
muscle atrophy, and the molecular determinants that control muscle mass remain incompletely defined. Using
conditional genetic engineering, we have identified a surprising new role for the B cell lymphoma 6 (BCL6)
transcriptional repressor to maintain muscle mass. Herein, we propose to comprehensively dissect the function
of BCL6 in muscle and its epigenomic regulation. In Aim 1, we will test the impact of BCL6 on muscle protein
synthesis and degradation, muscle mass, myofiber specification and metabolism, strength, and whole body
energy homeostasis. In Aim 2, we will define the genome-wide gene regulatory network for BCL6 and its
epigenomic, molecular, and biochemical mechanisms for controlling proteostasis. Together, these studies will
reveal new molecular insights and a potential therapeutic pathway to reduce the burden of skeletal muscle loss.

Public health relevance
Loss of muscle mass occurs in many diseases or as a consequence of aging. It is associated with loss of independence, risk for illness, as well as death, and it may disproportionately affect veterans compared to the general population because of their age and disabling medical conditions from military service. Aside from exercise, there are no current therapies. In this project, we elucidate a gene switch controlling muscle mass. Insights from these studies may identify a therapeutic pathway to halt or reverse muscle loss.